DEVELOPMENTAL STUDY OF VASCULAR ATRIAL NATRIURETIC FACTOR RECEPTORS

This study examines whether atrial natriuretic hormone receptor sites are present in the human placenta and umbilical cord and whether the numbers of receptors change as pregnancy progresses.